CCN1-induced Senescence in the Cerebral Vasculature

Project Summary
Vascular contributions to cognitive impairment and dementia (VCID) includes a number of different disorders
identified by cognitive deficits secondary to cerebrovascular pathology. Senescence in the cerebral endothelium
has been proposed as a mechanism that can drive blood brain barrier disruption (BBB), which precedes VCID.
However, the mechanisms that drive endothelial cells to senescence are not fully understood.
Guanine-quadruplex (G4) is a non-canonical secondary structure formed in G-rich sequences in DNA and
RNA. Importantly, G4 stabilization promotes cellular senescence. Particularly, stabilization of G4s in mRNA
(rG4s) stalls ribosomes in the elongation stage and blocks translation. This mechanism is promoted by rG4-
binding proteins. Fragile X mental retardation protein (FMRP) binds to the rG4 of tumor suppressors and
components of signaling pathways involved in senescence. FMRP deficiency has been associated with
senescence in different tissues. We found that overexpressing FMRP in cultured cerebral endothelial cells (CEC)
mitigated DNA damage, an important cause of cell senescence.
We found that G4 stabilization promoted endothelial senescence and enhanced the levels of Cysteine-rich
angiogenic inducer 61 (Cyr61/CCN1), a matricellular protein secreted by endothelial cells in the brain. CCN1 is
considered a component of the senescence-associated secretory phenotype (SASP). In fibroblasts, CCN1
induces senescence by binding to integrin α6β1.
In our study, we will use bilateral carotid artery stenosis (BCAS) that induces chronic cerebral hypoperfusion and
models VCID in mice. We found that BCAS mice showed enhanced levels of G4s, CCN1 and senescence
markers.
We hypothesize that the endothelial senescence associated with G4 stabilization could be mitigated in mice and
hence prevent BBB disruption and cognitive deficits. To test our hypothesis, we propose two aims:
In Aim 1, we will selectively target the brain endothelium of young mice with a vector encoding a mutant form
of CCN1 that cannot bind to α6β1. We will measure motor and cognitive function, and BBB permeability, and
senescence in the brain.
In Aim 2, we will determine if upregulating FMRP mitigates motor and cognitive deficits, BBB impairment, and
senescence in the cerebral vasculature of aged BCAS mice.
Overall, this study proposes two independent strategies to mitigate VCID-associated phenotypes induced by
senescence in the cerebrovasculature: impeding the CCN1-α6β1binding in the cerebral endothelium; and
upregulating FMPR specifically in the brain vasculature of mice.

Public health relevance
Project narrative Vascular contribution to cognitive impairment and dementia (VCID) is the second form most common of dementia and may contribute to up to 20% of cases. This project proposes that a protein secreted by the cells that form blood vessels in the brain contributes to aging of the brain, and that preventing its synthesis can mitigate phenotypes associated with VCID. We will use molecular techniques to target specifically blood vessels in the brain of mice, a mouse model that recapitulates some of the features seen in VCID patients, and microscopy systems to explore the pathological mechanisms that underlie VCID.